The Role of SoxE Transcription Factors in Neural Crest Cell Specialization

Project Summary/Abstract
Neurocristopathies are a class of syndromes that are predominately characterized by malformations in the
craniofacial complex. These defects are caused by aberrant development of the neural crest, a stem cell
population unique to vertebrates. One distinctive feature of the neural crest is their ability to give rise to both
ectomesenchymal (bone/cartilage) and non-ectomesenchymal (melanocytes and peripheral neurons/glia)
derivatives. SoxE transcription factors play important roles in both the formation and the diversification of the
neural crest. All three SoxE factors (Sox8, Sox9, and Sox10) function redundantly to promote neural crest
formation. Interestingly, individual SoxE factors direct the differentiation of the neural crest into distinct lineages.
Sox9 promotes chondrogenesis while Sox10 supports both the melanocyte and peripheral neuron/glial fates. An
outstanding question is how these highly similar SoxE factors lead to neural crest specialization. This proposal
utilizes omics-based approaches, gain and loss of function experiments, and Sox9-Sox10 chimera constructs to
assess how and when SoxE-mediated neural crest specialization occurs. Furthermore, mutations in SOX9 and
SOX10 are causative for Campomelic dysplasia and Waardenburg syndrome, respectively. The syndromes
present with very different craniofacial phenotypes which are reflective of SOX9/SOX10 specific defects during
neural crest specialization. Work from this study will lead to the identification of novel SoxE transcriptional targets,
determine when SoxE factors begin to promote neural crest specialization, and determine how specific patient
variants for Campomelic dysplasia/Waardenburg syndrome cause disease phenotypes. Overall, this work is of
high clinical significance and will provide evolutionary insights into the molecular origins of neural crest
diversification. My primary goal for the mentored phase of this proposal is to identify when SoxE factors begin to
promote lineage specialization within the neural crest and determine the functional domains that contribute to
SoxE family subfunctionalization. I plan to use my remaining time as a postdoctoral fellow to master new
experimental techniques and develop robust computational analyses. I will capitalize on the rich academic
environment of Northwestern University, especially the expertise in NSF-Simons Center for Quantitative Biology.
My long-term career goal is to establish an independent research program that uses multiple model systems to
investigate the cellular and molecular origins of syndromes characterized by craniofacial phenotypes. I plan to
use Sox transcription factors (and associated syndromes) as a starting point in my career, but then extend my
research interests to other gene families through collaboration with clinicians. My measurable experience with
various model organisms will allow me to investigate biochemical, molecular, cellular, and morphological aspects
of developmental disorders by exploiting the benefits of each model system.

Public health relevance
Project Narrative Craniofacial defects are among the most common of all congenital abnormalities. An embryonic population of cells called the neural crest gives rise to a significant portion of the craniofacial complex, including bone and cartilage of the face, pigment cells, and components of the peripheral nervous system. My work seeks to understand how a subfamily of transcription factors (SoxE) help the neural crest form the diversity of cell types in the face and how patient specific SOXE mutations cause Campomelic dysplasia and Waardenburg syndrome.